Annual Latin American Congress on OCD

PROJECT SUMMARY/ABSTRACT
Like many psychiatric disorders, the research on obsessive-compulsive disorder (OCD) to date has been
overwhelmingly performed on participants of European Ancestry. For example, the latest genome-wide
association study on OCD is about to be published, but unfortunately >95% of the OCD cases studied are entirely
European. Thankfully, NIMH has recently funded a study that will begin to increase diversity in OCD research,
the Latin American Trans-ancestry INitiative for OCD genomics (LATINO). In addition, OCD researchers
themselves have had a strong Eurocentric bias. One way to promote the inclusion of under-represented minority
(URM) trainees in OCD research is to help them network with other Latin American investigators studying OCD
as well as established investigators from outside Latin America. The LATINO project represents an opportunity
to facilitate this networking. To this end, the LATINO project has teamed up with the non-profit organization
Asociación Latinoamericana de Trastorno Obsesivo Compulsivo (ALTOC) to host an annual meeting on OCD in
Latin America. The first two meetings in 2022 and 2023 were transformative for many attendees, but
unfortunately, no funds existed for URM trainees to attend the meeting. This R13 proposal is designed to provide
travel awards for URM students, postdocs, and junior faculty to attend this annual meeting. Specifically, we
request funding for 10 travel awards per year over the next 4 years. We also request funds for professional, on-
site translation services to facilitate knowledge exchange. Each conference will also feature formal career
development and mentoring sessions to help travel awardees reach their full potential. Ultimately, our goal is to
foster the next generation of Latinx OCD researchers. We will follow the NIH Interest in Diversity statement and
consider all underrepresented populations in the U.S. biomedical research enterprise. We will use the categories
listed in the NIH Interest in Diversity statement to define underrepresented populations. In addition to applicants
of Latin American ancestry, this will extend the opportunity to, for example, Black, American Indian, individuals
with disabilities, and those from disadvantaged backgrounds.

Public health relevance
PROJECT NARRATIVE The existing research on obsessive-compulsive disorder (OCD) is heavily focused on individuals of European ancestry and performed by researchers who are also primarily of European descent. In this project, we request funds to provide travel awards for underrepresented minority (URM) trainees to attend a conference specifically focused on OCD in Latin America. The conference will feature career development and mentoring sessions designed to increase the representation of URM trainees.